Leadership, Planning, and Evaluation

Leadership, Planning and Evaluation: Summary/Abstract
Internal and external HDFCCC Leadership and Advisory Groups provide a robust mechanism for evaluating
Center-wide priorities and activities, reviewing individual programs and shared resources, and providing an
infrastructure to carry out responses to review processes such as those described above. Through these
various forums, Ashworth has connections to receive feedback from and provide feedback to UCSF research
and clinical leadership, peers in other research and clinical departments, HDFCCC executive leadership,
HDFCCC members, CCSG components, members of the catchment area community, and leaders from other
institutions and cancer centers. The HDFCCC leadership groups and advisory groups include: (1) the
Executive Leadership Group; (2) the Senior Leadership Group; (3) the Scientific Leadership Group; (4) the
Cancer Center Clinical Research Oversight Committee; (5) the Cancer Clinical Governance Board; (6)
Research Program Meetings; (7) the Internal Advisory Board; (8) the Community Advisory Board; and (9) the
External Advisory Board.